National User Resource for Biological Accelerator Mass Spectrometry

PROJECT SUMMARY
The National User Resource for Biological Accelerator Mass Spectrometry (User Resource) will provide ultra-
sensitive isotopic analysis (primarily radiocarbon or Carbon-14) by accelerator mass spectrometry (AMS) for
NIH-funded and other researchers. It will be the only User Resource of its type in the United States. The User
Resource will leverage 20 years of expertise in the development and application of AMS in broad-based
biomedical research through the Biomedical Technology Research Resource for the Development of
Biomedical Accelerator Mass Spectrometry (BTRRAMS): a NIGMS Biomedical Technology Center
(P41GM103483 09/01/2000 – 05/31/2020) that is in its final year of operation. Since June 2014, the
BTRRAMS has measured over 20,000 samples (4,000 a year) a year for its user community. The User
Resource will continue to meet the needs of current users as well as provide a capability for new users who
would benefit from incorporating AMS as a measurement tool into their research programs. The User
Resource’s forte will be ultra-high sensitivity quantitation of radiocarbon and selected other radioisotopes for
research studies where isotopes are required. Radioisotope labeling studies continue to be an important tool
for addressing many complex problems in the biomedical sciences. AMS is a specialized and unique type of
mass spectrometry that provides absolute quantitation of radiocarbon and relevant other isotopes with limits
of detection in real samples on the order of a few attograms/mg sample. As a National Resource, the most
significant work enabled by AMS is likely to be quantification of metabolic pathways in human health states
and comparison to ex vivo and in vivo animal models. The technology made available will enable a deeper
understanding of the etiology of human health concerns by (1) enabling the ability to quantify
pharmacokinetics and other molecular endpoints directly in humans; (2) offering the ability to conduct
quantitative studies using biologics such as proteins or lipids; and (3) enabling more relevant studies of
metabolic pathways in health and disease through the use of much lower, more biologically-relevant,
concentrations of metabolic substrates in cells and intact organisms. Such studies support NIGMS’s basic
biomedical research areas that contribute to the understanding of fundamental cellular and physiological
principles. The User Resource has three goals: (1) provide high throughput, ultra-sensitive 14C analysis for
the NIH user community ; (2) improve the efficiency of ultra-sensitive 14C analysis through installation of new
interfaces to our AMS systems, improvements in ion source efficiency and upgrades to our data analysis
codes; and (3) increase the accessibility and visibility of ultra-sensitive 14C measurements for the biomedical
research community by training new investigators and expanding the National user base of researchers
requiring ultra-sensitive 14C analysis.

Public health relevance
PROJECT NARRATIVE The National User Resource for Biological Accelerator Mass Spectrometry (User Resource) will provide ultra-sensitive Carbon-14 isotopic analysis by accelerator mass spectrometry (AMS) for NIH-funded researchers. The User Resource will enable a deeper understanding of the etiology of human health concerns by enabling quantification of pharmacokinetics and other molecular endpoints directly in humans; offering the ability to conduct quantitative studies using biologics such as proteins or lipids; and enabling more relevant studies of metabolic pathways in health and disease through the use of much lower, more biologically-relevant, concentrations of metabolic substrates in cells and intact organisms. The User Resource will increase the accessibility and visibility of ultra-sensitive 14C measurements by training new investigators and expanding the National user base while concurrently improving the efficiency of AMS measurements through installation of new interfaces, technical modifications to ion sources and upgrades to data analysis software for improved ease of use and data reporting.